Training in Cardiovascular Sciences for Undergraduate Rising Stars (CURS)

The “Training in Cardiovascular Sciences for Undergraduate Rising Stars (CURS)” is a competitive, structured undergraduate research opportunity designed to provide hands-on experience in cardiovascular sciences. Over 9 weeks, participants will engage in meaningful, hypothesis-driven projects under the guidance of experienced faculty and mentors. CURS is modeled after Columbia University's highly successful summer research program directed by the PI, Dr. Andrew Marks. CURS will provide extensive training in basic science research, and enhance the likelihood that the students will achieve a career in science by pursuing an advanced degree (M.D. and/or Ph.D.). The applicant pool for CURS has grown to well over 150 each year consisting of highly qualified student participants. Students selected for support through this program will perform hands on research for nine summer weeks under the mentorship of Columbia University cardiovascular faculty scientists (currently 97 Columbia University faculty receive NHLBI support). In addition to specific training in cardiovascular sciences, the students will receive in-depth training in research methodology including: (a) the design and analysis of experiments; (b) critical reading of scientific literature through journal clubs; (c) ethics in science; (d) the presentation of scientific results at laboratory meetings; (e) presentation of their research at poster sessions; (f) an oral presentation of their research to an audience of scientists; and (g) career counseling. In addition to mentored research projects, the program offers a series of scientific and motivational talks that provide the students with insights regarding career development, medical/Ph.D. programs, their medical/graduate school years, and the important aspects on which to focus in order to ensure a successful academic experience.

Public health relevance
PROJECT NARRATIVE The CURS program offers an incredible summer research opportunity for outstanding undergraduate students studying biological sciences nationwide. The goal is to train these students and to convince them of the opportunities available for a career in science. Therefore, the CURS program addresses the critical need to increase the pipeline of highly qualified trainees by inspiring students to pursue an advanced degree (M.D. and/or Ph.D.) in the cardiovascular sciences .